Left ventricular physiological effects of veno-arterial ECMO support during cardiogenic shock

Project Summary/Abstract
Cardiogenic shock is a devastating problem that has had a relatively stagnant in-hospital mortality around
30-40% in the last decade. Consequently, an array of mechanical support strategies has emerged to mitigate
the multi-organ hypoperfusion. Among them, percutaneous veno-arterial extracorporeal membrane
oxygenation (VA-ECMO) is increasingly being used to treat cardiogenic shock due to its capacity to be
instituted rapidly in the cardiac catheterization laboratory and provide large volume complete hemodynamic
and respiratory support. However, this strategy has notable disadvantages, namely high cost associated with
its programmatic development and the potential for introducing iatrogenic complications in a very sick
population.
Prior invasive hemodynamic data from animal models have suggested that there is deterioration of LV
performance due to increased stroke work within minutes of the commencement of VA-ECMO hemodynamic
support. There is also observational clinical data showing that LV distension may worsen with VA-ECMO
support. Conversely, human data from our group’s prior experience have suggested that VA-ECMO support in
patients with minimal pulsatility after out-of-hospital cardiac arrest can dramatically improve cardiac recovery
and rates of neurologically favorable survival.
These conflicting data have led to the emergence of diverse management strategies including VA-ECMO in
patients with cardiogenic shock either due to AMI or cardiac arrest. In the context of the rapidly increasing
usage of VA-ECMO usage there is a critical need to identify the manner in which VA-ECMO affects cardiac
hemodynamics in the setting of cardiogenic shock.
To that goal we will pursue the following specific aims:
1. Define the LV pressure volume area (PVA) and stroke work at different levels of VA-ECMO support in
patients cannulated for CS. 2. Define the temporal changes of LV stroke work with prolonged VA-ECMO
support over the course of the hospitalization. The temporal recovery patterns will be associated with clinical
hard endpoints of decannulation or transition to permanent cardiac assist devices/transplant or death.
3.Validate the accuracy of non-invasive reconstruction of PV-loops compared to invasively collected data to
help establish an easier way to assess LV stroke work for every day practice.
The expected outcome of this research proposal is to define the physiologic effect of VA-ECMO support on
the left ventricle energetics and provide objective scientific clinical proof derived from a high mortality and
morbidity patient population. Additionally, we expect that our data will be useful to establish normative
hemodynamic and imaging principles and strategies for assessing patients on VA-ECMO.

Public health relevance
Project Narrative This research will evaluate the effects that an artificial heart and lung machine (ECMO) has on the work load of the beating heart in patients supported because of heart problems that lead to shock. We will assess: 1) how the presence of ECMO unloads or stresses the heart with different levels of support in the cardiac catheterization laboratory, 2) evaluate how this effect varies over time and affects cardiac recovery, and 3) compare a non-invasive method to reconstruct the PV loops with the invasive gold standard in order to provide an easier way to assess those changes. The results will help us make educated decisions about the use of circulatory assist devices and clarify the physiological effects they have on the heart.